Skin Stem Cells and Their Niche Interactions

Project Summary/Abstract
The global objective of this research is to elucidate the mechanisms underlying tissue homeostasis and
regeneration in mammalian skin and to understand how this process goes awry in human disorders, including
cancers. Central to achieving this goal is the characterization of the different stem cells (SCs) within skin,
determining their relative contributions to tissue homeostasis and wound-repair, and elucidating how changes in
their niche microenvironments impact these events. Past AR050452 research led to purification of hair follicle
(HF) bulge and basal inter-follicular epidermal (Epd) cells and established them as long-lived, self-renewing SCs
that function in tissue regeneration and wound-repair. However, both in their biology and their tissue regenerative
tasks, these SCs display distinct behaviors predicated by their unique microenvironments (niches). The field still
lacks a comprehensive knowledge of the constituents of these niches, the nature of SC:niche interactions, and
how they help SCs cope with stressful situations. Past AR050452 research set the foundations to tackle the next
key questions: (1). What are dynamics in bulge niche components that drive HFSC behavior during the hair
cycle? (2) What are the key niche:HFSC interactions that maintain quiescence and drive tissue (hair)
regeneration and how do they differ from the niche: short-lived progeny interactions that drive hair differentiation?
(3) How are HFSCs spared during the destructive phase of the cycle when hair growth ceases and most follicle
cells below the bulge apoptose? Does eating confer increased SC fitness? (4) How do HFSC:niche interactions
change when skin is injured and the SCs become repurposed to repair the wound? How do SCs protect
themselves against immune/pathogen attack so that they can orchestrate the re-epithelialization process? (5)
How does the natural process of wound-repair differ from the behavior of a SC when it acquires an oncogenic
mutation that will ultimately lead it down a path to cancer? To answer these questions, we'll use FACS, single
cell spatial transcriptomics and chromatin landscaping, conditional gene knockout and RNAi screens in vivo and
employ these methods to explore skin stem cells in their native, wound-induced and tumorigenic environments.

Public health relevance
Project Narrative Stem cells (SCs) are natural units of tissue repair and homeostasis, and their versatility holds promise for tissue regeneration. This research uses the skin epithelium as a model to delineate the crosstalk that SCs undergo with their local microenvironments which enable SCs to self-renew and survive long-term during normal tissue homeostasis and in response to injuries. Understanding how SCs cope with stress and with breaches in the epithelial barrier is a fundamental prerequisite to ascertaining the potential of SCs for regenerative therapies and to devise new and improved therapeutics for inflammatory disorders and cancers.